Impact of Medicare Polices on Beneficiaries with ADRD

Abstract
Medicare beneficiaries with Alzheimer’s Disease and Related Dementias (ADRD) experience progressive
cognitive impairment and frequently require assistance to manage their complex care needs at home.
Medicare pays Home Health Agencies (HHAs) billions of dollars annually to provide home care, including
skilled nursing and rehabilitation therapies. Because of concerns about the quality and value of HHA services,
Medicare has two new payment policies: a) switch to a case-mix payment system, the Patient Driven
Groupings Model (PDGM) in 2020; and b) implementation of the Home Health Agency Value Based Payment
(HHVBP) program in 2023. Neither program, however, addresses potential differences in outcomes due to
social factors, such as individual-level race/ethnicity or area-level social capital, despite past experiences
where new Medicare payment policies that ignored social factors exacerbated disparities. Evidence on the
impact of the new policies on HHA service use is limited, especially as the national HHVBP implementation
starts in 2023. Any evaluation will require accounting for contemporaneous changes in other policies, and
attention to how the pandemic is impacting who receives HHA services or how care is delivered. Thus, to
examine the impact of HHA services on beneficiary outcomes, we propose three aims: 1) to characterize
changes in the population of community-dwelling beneficiaries eligible for HHA services and enrolled in
traditional, fee-for-service Medicare (TM), accounting for switches to Medicare Advantage (MA), transitions to
long-term nursing homes, and increases in new ADRD diagnoses after the introduction of greater financial
incentives for ADRD coding; 2) to evaluate the impact of PDGM and HHVBP policies on HHA use in TM
beneficiaries with ADRD compared with similar beneficiaries enrolled in MA; and, 3) to examine the effect of
HHA service use on clinical events, such as hospitalizations, long-term nursing home admission, or mortality,
among TM and MA beneficiaries with ADRD. Our three aims are complementary and address a critical service
for vulnerable beneficiaries with ADRD while carefully examining population and delivery changes occurring
over time. We will use multiple data resources to capture the changes; then to address the complexity of the
data, we will use ensemble machine learning approaches combined with longitudinal targeted maximum
likelihood estimation methods to assess the average HHA treatment effect as well as potential effect
heterogeneity with respect to social factors measured at the individual and area levels. Study findings could
inform policy makers, clinicians, patients, and families about the impact of HHA services over time and
potential variation in this impact with respect to social factors.

Public health relevance
Narrative Medicare has reformed the provision of home-based medical and rehabilitation services with two major new policies. These policies have the potential to improve care for patients, particularly those with Alzheimer’s Disease and Related Dementias, but also might worsen disparities in access, use, or outcomes of care. Evaluations of patient outcomes need to account for changes during this same time period in other Medicare policies as well as from the COVID-19 pandemic. Such evaluations will be vital to policymakers and the future clinical care of patients with ADRD.